Characterization of innate immune signaling pathways in the tick Ixodes scapularis

Project Summary
Ticks are vectors of Lyme and other established and emerging diseases of increasing health relevance
in the United States and Europe. Prevention of tick-borne illnesses would be significantly aided by improving our
understanding of immune signaling in ticks. Ixodes scapularis is an arthropod vector of the Lyme disease
spirochete Borrelia burgdorferi, the rickettsial pathogen Anaplasma phagocytophilum, and other pathogens.
Comparison of genes encoded by the I. scapularis genome with genes in Dipteran insects reveals some
conservation of immune signaling pathway components, including JAK/STAT, IMD/JNK, and STING pathway
components. However, it is also becoming abundantly clear that immune signaling in I. scapularis and other ticks
is significantly different, such that there is a need for direct study. The long lifecycle of the tick, the uniqueness
of pathogens they transmit, the state of tick gene annotations, and a relative lack of molecular genetic tools have
previously been barriers to systematically studying arthropod-microbe interactions. Recent work by our group
and others has begun to fill these gaps. For example, our laboratories have developed molecular genetic
methods for tick cell studies and applied single-cell RNAseq to tick immune cells (hemocytes). These
advancements facilitate application in the tick system of systematic strategies that take advantage of a cell
culture system and ‘omics technologies for relatively rapid discovery, including unbiased identification of potential
new innate immune pathway components, followed by functional validation by observing the effects of perturbing
the new candidate pathway genes on pathway activity. Altogether, we will combine cell cultured-based methods
with in vivo assays in I. scapularis, performed in the presence of B. burgdorferi or A. phagocytophilum, to identify
signaling factors and test their relevance in microbe-arthropod interactions. Notably, the project will both
interrogate conserved factors and identify new factors via functional-based approaches. This project will result
in a significantly expanded understanding of innate immune signaling in ticks, paving the way for further study of
this health-relevant topic and development of new interventions for the prevention of tick-borne diseases.

Public health relevance
Project Narrative Our understanding of tick responses to infection by human health-relevant microbes such as the Lyme pathogen Borrelia burgdorferi would be aided by efficient unbiased identification and functional validation of components of tick innate immune signaling pathways. We will leverage technological advancements made by our groups to significantly expand our understanding of innate immune signaling in ticks via efficient identification of new gene candidates in tick cells and in vivo validation.